ECOG-ACRIN Network Group Statistics and Data Management Center

This grant will provide support for the Statistics and Data Management Center (SDMC) of the ECOG-
ACRIN Cancer Research Group. The SDMC is organized and operated jointly by the Department of
Biostatistics and Computational Biology at the Dana-Farber Cancer Institute (DFCI), the Department of
Biostatistics at Brown University, the ECOG-ACRIN Medical Research Foundation (EAMRF), and the
American College of Radiology (ACR), under the direction of the Group Statisticians. The primary
responsibility for data collection and management belongs to the Data Management Center, consisting
of EAMRF and ACR. The primary responsibility for study design, monitoring, and analysis, and for
overseeing and coordinating SDMC operations, belongs to the Biostatistics Center, consisting of DFCI
and Brown University. The primary contact site for grant administration is DFCI. ECOG-ACRIN is a
multi-modality group conducting a wide range of studies, including definitive phase III trials of
therapeutic interventions, earlier phase studies developing new therapies, studies focused on
diagnosis and of advanced imaging methods, investigation of laboratory and imaging based
biomarkers, and studies incorporating patient reported outcomes. The SDMC is responsible for all
quantitative aspects of EA’s activities. Our overall goals are to conduct clinical trials to the highest
standards in statistical methods, data management, and regulatory compliance, while continually
improving efficiency of all of our processes and systems to optimize the use of our limited resources.
Areas of particular focus in this grant include studies incorporating tissue and imaging biomarkers to
direct therapy, studies of immunotherapy, studies of de-intensification of therapy to reduce morbidity,
studies investigating novel biomarkers, and studies investigating the relationship of biomarkers and
therapy in populations defined by race, ethnicity, gender, and age.

Public health relevance
The overall purpose of this grant is to provide expertise in statistics and data management to support the research mission of the ECOG-ACRIN Cancer Research Group. Achievement of our objectives will enable ECOG-ACRIN to continue to produce high quality clinical studies that advance the care of cancer patients.